The effects of poverty reduction intervention on health outcomes among women and young children in low- and middle-income countries

ABSTRACT
Poverty long has been recognized as an important social determinant of health. Despite many years of progress,
in 2018 nearly 10% of the world's population lived in extreme poverty — below $1.90 per day. The Covid-19
pandemic has further increased poverty, leading to a 12% increase in extreme poverty in 2020, with ongoing
increases in low-income countries in 2021. Large-scale, government-led cash transfer programs that provide
money to individuals or households (with or without conditions) have been a vital part of poverty reduction
strategies in many countries during the past two decades. Unlike multi-country evaluations of major health aid
programs like PEPFAR, the vast majority of studies of cash transfer programs have focused on individual
countries and impacts on beneficiaries in those countries, generally using datasets that are not large enough to
precisely estimate effects on mortality rates and many other important health outcomes. In recent work, we used
data from 37 low- and middle-income countries (LMICs) and numerous Demographic and Health Survey (DHS)
surveys to generate longitudinal mortality datasets for about 7 million adults and children. Using a difference-in-
differences approach, we found that government-led cash transfer programs resulted in large and statistically
significant reductions in mortality among adult females (adjusted risk ratio 0.80) and children <5 years of age
(adjusted risk ratio 0.90), but not among adult males or older children. This work raises an important question
about the possible pathways that explain these findings, including behavioral pathways (such as increased
engagement in health-promoting behaviors like antenatal care or childhood vaccination) as well as health and
nutrition pathways (such as improved child nutrition). The proposed project will address this question by
combining DHS data with our newly constructed database of cash transfer programs, using difference-in-
differences analyses to examine the association between cash transfer programs and outcomes among adult
females and children <5 years of age. Aim 1 of the project will assess the association between cash transfer
programs and key behavioral outcomes that might affect mortality rates and other health outcomes, and Aim 2
will assess the associations between these programs and key health and nutrition outcomes that are of
considerable interest themselves and might also mediate effects of cash programs on mortality rates. Regression
models will include country and year fixed effects and time-varying confounders at the individual- and country-
levels. We will conduct secondary and sensitivity analyses like temporal analyses and alternative modeling
approaches to assess the robustness of our results, including use of alternative estimators to address bias that
can be introduced in difference-in-differences analyses with variation in intervention timing. At a time when many
countries are considering scaling-back or expanding cash transfer programs, this project has the potential to
have timely public-health and policy impact by producing a comprehensive, global assessment of the causal
effects of cash transfer programs on key child- and maternal-health outcomes.

Public health relevance
PROJECT NARRATIVE Poverty has long been recognized as an important social determinant of health, and we recently showed that large-scale, government-led cash transfer programs lead to important reductions in mortality among women and young children in low- and middle-income countries. Through this project, we seek to examine pathways that might explain these reductions using national survey data from dozens of low- and middle-income countries. At a time when many countries are considering scaling back or expanding cash transfer programs, this project has the potential to have timely public health and policy impact by producing a comprehensive, global assessment of the causal effects of cash transfers on key child and maternal health outcomes.